IDENTIFICATION OF SUBSTRATES OF YEAST AGC KINASES YPK1 AND YPK2

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this collaboration is to identify targets of the yeast AGC kinases Ypk1 and Ypk2, using biochemical and proteomic approaches.